Interactions of Streptococcus mutans in Supragingival Biofilms

PROJECT SUMMARY / ABSTRACT
The microbes that inhabit oral biofilms attached to the tooth’s surface are constantly involved in interactions
with other microbes that impact their ability to survive and grow within their niche. Streptococcus mutans, a
primary driver of dental caries (tooth decay) development, forms rotund microcolonies on the surfaces of teeth
that are in contact with other commensal bacteria, particularly health-associated Streptococcus species that
encode mechanisms to deter S. mutans emergence and initiation of the cariogenic cycle. Outgrowth of S.
mutans leads to ecological shifts within the oral microbiome community, reducing the proportions of health-
associated streptococci and instead promoting the outgrowth of other acidogenic and aciduric bacteria that
then further drive the disease (caries) process. Therefore, describing the initial interactions that occur between
S. mutans and commensals is of critical need in the field of oral health to begin understanding factors that
influence S. mutans establishment, persistence and outgrowth. Discovering gene(s) and/or pathway(s) that
could serve as potential therapeutic targets to thwart the appearance of Sm while keeping the normal,
protective flora intact remains a favorable strategy towards caries prevention and overall maintenance of good
oral health. Recently, our group described a novel gene expression pattern within S. mutans when it was
grown in mixed-species cultures with health-associated streptococci. Interestingly, this gene expression pattern
was consistent with multiple Streptococcus species, suggesting that this may be a common S. mutans-
encoded response to these competitors. Our central hypothesis is that the mixed-species gene expression
pattern provides a fitness benefit to S. mutans during the early stages of biofilm establishment and allows S.
mutans to compete with health-associated commensals, particularly streptococci. Our objective is to first fully
describe the S. mutans gene expression pattern during mixed-species growth with different groups of oral
bacteria not currently tested, including health-associated non-Streptococcus species and disease (caries)-
associated species. This will allow us to determine if the gene expression pattern observed previously is
unique to health-associated streptococci or common during all S. mutans mixed-species interactions. We will
then aim to determine if differentially-expressed genes, particularly up-regulated S. mutans genes previously
identified and pre-selected through collected preliminary RNA-Seq data, provide a fitness benefit to S. mutans
during mixed-species growth and whether these gene(s)/gene product(s) could serve as future therapeutic
targets. We hypothesize that several S. mutans genes will emerge that will significantly modify S. mutans
fitness in mixed-species interactions and/or significantly alter Sm rotund microcolony formation which are
critical for the caries disease process. Together, these aims will advance our understanding of how S. mutans
responds to intermicrobial competition, and whether we can leverage these interactions to design new
strategies to prevent S. mutans emergence within the oral microbiome.

Public health relevance
PROJECT NARRATIVE The dental caries (tooth decay) pathogen Streptococcus mutans lives in multi-species biofilms and commonly interacts with other oral bacteria. This research project is designed to determine how S. mutans changes its gene expression when encountering other species of oral bacteria, and whether these gene expression changes provide a fitness benefit to help S. mutans grow and compete against them.